Neuroanatomical substrates underpinning brain aromatase control of feeding behavior and metabolic homeostasis

Project Summary
Estradiol orchestrates feeding behavior and metabolism. Aromatase is the sole enzyme responsible for
producing estradiols from androgens, and it is highly expressed in gonads. In humans and rodents, neurons in
discrete brain regions densely express aromatase. The role of brain aromatase and locally de novo (brain)-
derived estradiols in energy balance control remains poorly understood. Our goal is to provide answers for
several pressing basic questions: – is brain-aromatase necessary for feeding and energy balance control? Is the
role of brain aromatase neuroanatomically and sex divergent? How do brain and gonadal aromatase interact in
metabolic control? We identified two populations of aromatase-expressing neurons, in the central nucleus of
the amygdala (CeA) and in the ventromedial hypothalamus (VMH), in female and male rats. Our preliminary
data suggest aromatase specifically in the CeA controls feeding behavior and subsequent weight gain in a sex-
specific manner. In contrast, aromatase in the VMH, exerts control over the brown adipose tissue thermogenic
capacity and response, in both sexes. Therefore, in this project we will pursue the hypothesis that aromatase in
the CeA is critical to feeding behavior control in a sex-selective manner, while aromatase action in the VMH has
the primary role of energy expenditure control in both males and females. We further posit that aromatase in the
VMH, but not CeA, may be particularly important under conditions of metabolic challenges and pathophysiology.
The proposed studies combine behavioral, metabolic, neuroanatomical, molecular, and virogenetic strategies in
adult rats to support or refute this hypothesis by conducting detailed mechanistic experiments organized in two
aims. In Aim I we strive to identify the specific contribution to feeding control and downstream mechanisms
orchestrated by amygdala aromatase. Here we will resolve whether CeA aromatase is necessary and sufficient to
control food-motivated and ingestive behavior. We will determine whether local, intra-amygdala, and distal,
lateral hypothalamic sex-specific pathways are engaged by CeA aromatase neurons, and whether loss of this
input leads to disinhibition of hypothalamic orexigenic pathways. The specific broad goal of Aim II is to test
whether hypothalamic aromatase controls feeding and thermoregulation under normal and metabolically
challenging conditions. We will examine whether aromatase in the VMH is necessary and sufficient for energy
expenditure and body weight control in both sexes. Experiments here are also designed to reveal whether VMH
aromatase has a critical role in adaptation to metabolic challenges: obesogenic diet and cold exposure, in both
sexes. Finally, and in contrast to CeA, we hypothesize that VMH aromatase and resulting estradiol are responsive
to and work in concert with gonadal steroids. If our hypothesis is supported, we will show that brain aromatase
and resulting locally produced estradiols are key to maintenance of energy balance during metabolic health and
disease.

Public health relevance
Project Narrative Our basic research is focused on elucidating the connections and functions of aromatase neurons relevant to energy balance control. In addition to the urgent search for novel controls of body weight with the hope of identifying new anti-obesity treatments, the urgency of the current proposal is increased by the fact that pharmaceuticals inhibiting aromatase production are prescribed to many women yearly. They are capable of crossing the blood brain barrier, and their ability to affect behavior and metabolism via action on brain aromatase is poorly understood.